NIH Health Care Systems Research Collaboratory-Coordinating Center (U24)

ABSTRACT
Over the past nine years, the Collaboratory Coordinating Center (CC) has worked with the NIH to nurture 21
Demonstration Projects by providing leadership, resources, tools, training, and coordination of diverse
elements. Six of these trials were designed to speed scientific solutions for addressing the national opioid
public health crisis. The CC maintains expert Core Working Groups and committees; supports dissemination
and implementation efforts; and established the online Living Textbook of Pragmatic Clinical Trials to translate
learnings for the research community. The Collaboratory CC has created and disseminated guidance so that
investigators can work with health systems to embed their research in the delivery of health care, and use
routinely collected health care information as a core data source for the full spectrum of clinical research,
including randomized trials. The Collaboratory CC is also providing essential guidance to funders, reviewers,
institutional review boards (IRBs), and data safety monitoring boards regarding the ethical and regulatory
aspects of embedded pragmatic clinical trials (ePCTs).
In this next phase of work, we will build on lessons learned and new experiences gleaned from the next set of
Demonstration Projects to continue to refine the pragmatic trials model (Aims 1-3).
During the next funding period, the Collaboratory CC will have the following Specific Aims:
Specific Aim 1: Work collaboratively with each Demonstration Project team supported through the
Collaboratory program, including their partnering health care systems, to develop, test, and implement the
proposed Demonstration Projects while providing technical, design, and coordination support.
Specific Aim 2: Further develop and refine technical and policy guidelines and best practices for the
effective conduct of research studies in partnership with health care systems.
Specific Aim 3: Learn, develop, and disseminate the best strategies for conducting successful embedded
pragmatic clinical trials by engaging health care systems—including those with less historical involvement in
research studies—as research partners to improve health and care delivery.

Public health relevance
PROJECT NARRATIVE Over the past 9 years, the National Institutes of Health (NIH) established a Health Care Systems Research Collaboratory (Collaboratory) worked to strengthen the national capacity to implement cost-effective large- scale research studies that engage health care delivery organizations as research partners.